Development of a patient-provider decision aid for HIV post-exposure prophylaxis

PROJECT SUMMARY
While many questions remain regarding specific rates for HIV PEP preventable transmissions related to the
real world challenges of HIV seroconversion and measuring risk, we do know that: 1) among individuals who
experience a known exposure HIV PEP is effective and potentially cost saving if initiated in a timely manner
and completed fully; 2) patients who have been offered, accepted, and even completed HIV PEP continue to
report confusion and inaccurate information regarding its use; and 3) in many contexts decision aids have
demonstrated improved patient knowledge regarding decision making, decreased decisional conflict, and
improved patient-provider communication. Given these gaps, the long-term goal of this work is to develop,
refine, and validate a technology-delivered patient-provider decision aid to assist providers in better
understanding and effectively implementing HIV PEP in practice, and assist patients to better understand the
decision they are making when provided with HIV PEP as an option so that they may more successfully 1)
make the decision, and 2) complete the entire 28-day course of mediation when they decide to initiate HIV
PEP.
The proposed patient-provider decision aid leverages a known clinical opportunity to engage patients who are
at risk for seroconversion in initiation of HIV PEP. By creating an internet-delivered multimedia tool that: 1)
removes provider biases regarding what qualifies as an HIV risk from the discussion process; 2) slows the
process of information sharing and decision making down and presents information in short, repeatable
modules; and 3) incorporates an opportunity for patients to reflect on key priorities that have been shown to
impact decision making and adherence (e.g. social support/stigma, HIV risk perception, cost/access, side
effects) prior to making the decision we anticipate that patients will have less decisional conflict, feel more
confident about their decision, and for patients who initiate HIV PEP, be more able to complete the entire 28-
day regimen.
Lastly, the proposal includes relationship building via a community advisory board to support all steps of the
patient-provider decision aid development and subsequent testing. Principles of design justice (e.g. adopting
co-design methods, developing specific mechanisms for accountability, centering the needs of marginalized
users) will be used to partner with this group of patient and health care providers to design aspects of
intervention content, and plan details of the future efficacy testing study.

Public health relevance
PROJECT NARRATIVE HIV PEP is an underutilized and understudied tool in the current HIV epidemic. The long-term goal of this work is to develop, refine, and validate a technology-delivered decision aid to assist providers and patients in understanding and using HIV PEP in their practice and lives. Successfully improving HIV PEP implementation and understanding can improve care and outcomes for a highly marginalized group of individuals at risk for HIV.